Investigating the Mechanistic Role of Dietary Protein in Aging and in Alzheimer's Disease

Project Summary
Dietary protein is a powerful determinant of the biological state and represents a vital element in a comprehensive
geroprotective therapy. Several groups have demonstrated that the manipulation of dietary protein levels can
directly influence the aging process. Specifically, the reduction of protein intake (PR) robustly enhances
metabolic health, promotes healthspan, and extends lifespan. Unpublished data from the Lamming Lab further
demonstrates in an early onset model of Alzheimer’s disease (3xTg-AD) that PR improves glucose tolerance,
reduces tau hyperphosphorylation, and ameliorates cognitive deficits. However, a recent conflicting report
suggests that a high protein diet can reduce the accumulation of Aβ in the brains of Alzheimer’s disease (AD)
patients. This indicates that further understanding of PR’s molecular mechanisms is necessary to appreciate the
true contribution of dietary protein in the aging process. In investigating the components of a PR diet, the
Lamming Lab has reported that isoleucine restriction (IleR) alone can effectively recapitulate PR’s benefits and
is required for a significant portion of PR’s effects. To further understand the role of IleR as a geroprotective
therapy, young C57BL/6J male mice were fed an IleR diet and concurrently treated with rapamycin, which is a
well-studied life-extending drug with proven benefits in AD mouse models. Surprisingly, rapamycin largely
overtook the short-term effects of the diet, blocking IleR’s benefits in body composition, glucose tolerance, and
energy expenditure. At the molecular level, rapamycin specifically prevented the induction of lipolytic programs
and not of thermogenesis or lipogenesis in the inguinal white adipose tissue. Lipolysis and lipid regulation plays
a critical role in the systemic state of metabolism. While the effect of PR on brain lipid regulation is unknown,
recent publications have found that dysfunctions in lipolysis is associated with AD progression. As such, this
proposal investigates the overarching hypothesis that lipolysis regulation is a critical mechanism of action in the
physiological role of dietary protein, with a focus on healthspan, lifespan, and cognitive health. Aim 1 will define
the metabolic and molecular interactions between rapamycin and various dietary restrictions and investigate the
role of dietary protein concentrations on the life-extending effects of rapamycin. Aim 2 will leverage transgenic
mouse lines with genetic ablation of putative rapamycin targets in order to dissect the molecular mechanisms
responsible for the effects of PR. Aim 3 will determine the role of dietary protein on the development of AD
symptoms and on the effects of rapamycin in the early onset 3xTg-AD and the late onset hAβ-AD mouse models.
We will further characterize changes of the lipidomic profile in the serum and the brain. In summary, this research
program seeks to provide significant advancements in our mechanistic understanding of the role of dietary
protein in the biology of aging as well as in the manifestation of AD pathogenesis.

Public health relevance
Project Narrative The extension of lifespan that is disease-free and cognitively lucid is the most pressing research goal in present- day’s rapidly greying global population. Leveraging a newly discovered diet-drug interaction, this project investigates the role of dietary protein levels in the physiological response to lifespan extension and in the amelioration of cognitive deficits in early and late onset mouse models of Alzheimer’s disease. Long-term benefits of this research program will clarify how the variables governing the metabolic state, such as our protein intake, can be manipulated to optimize our biological predisposition for a long and healthy life.